Summer Research Experience in Environmental Health (SREEH)

Abstract
Environmental health challenges require a well-trained workforce that possesses the skills and analytical
acumen to confront emerging threats. As such, it is crucial that we train the next generation of environmental
health scientists. To fulfill this need, undergraduate students should be made aware of the rewarding personal
and professional opportunities that await them in a career involving environmental health research or policy
development. We propose to establish an R25 Summer Research Experience in Environmental Health
(SREEH) program that will introduce a diverse group of undergraduate students in Connecticut (CT) to
research involving five innovative topics: climate and energy impacts on health, the developmental origins of
human disease, green chemistry solutions, understanding and overcoming health disparities, and novel
approaches to assessing environmental exposures and early markers of effect. Exposing students to these
exciting and challenging areas will give them the opportunity to go beyond the typical undergraduate
curriculum in a dynamic summer experience that will show them how they can be a part of critical research in
the environmental health sciences (EHS). This experience will motivate them to pursue higher education, and
inspire and prepare them for careers in EHS. The program will leverage the unique expertise of the faculty of
Yale University, and provide a 10-week mentored, hands-on introductory research experience that has five
main objectives: 1) to provide an engaging and intensive learning experience in hypothesis-directed research
in EHS; 2) to provide classroom instruction focused on emerging topics and tools in EHS research; 3) to
enhance scientific communication skills; 4) to nurture and provide support for pursuing higher education and
careers in the EHS; and 5) to disseminate student accomplishments and assessment metrics within the
scientific community to encourage more students to pursue a career in EHS. The program will draw upon the
unique resources, infrastructure, and expertise of faculty members from the Yale Schools of Public Health,
Forestry & Environmental Studies, Medicine, and Engineering & Applied Science. Students will also benefit
from meetings with state government officials who will bring practical risk assessment and policy perspectives
to the summer experience. Students will be recruited from CT universities, with a focus on attracting students
from under-represented backgrounds. The program will involve weekly meetings with an assigned faculty
mentor to receive one-on-one training, weekly seminars, workshops on a broad range of skill-building and
career development topics, field visits, and daily research activities. The program will culminate with student
oral presentations of their research efforts. Program graduates will be enrolled in the Yale SREEH alumni
network to facilitate graduate school applications and career development. Achievement of program outcomes
will be monitored continuously by an independent educational evaluator to ensure that the program meets its
objectives, maintains a high level of excellence and continues to improve in subsequent years.

Public health relevance
Narrative We propose a summer research training program that will introduce a diverse group of undergraduate students in Connecticut (CT) to five major emerging topics and tools in environmental health research: climate and energy impacts on health, the developmental origin of disease, green chemistry, environmental health disparities, and novel approaches to assessing environmental exposures and early markers of effect. Introducing students to these exciting areas of environmental health and allowing them to gain insights to the application of environmental health research will motivate them to pursue higher education, and inspire and prepare them for careers in the environmental health sciences.